National Health and Nutrition Examination Survey, Allergy Component/Study

This project will provide support to the National Center for Health Statistics (NCHS), for the Allergy Component/Study in the 2025-2026 National Health and Nutrition Examination Survey (NHANES).